CHRONIC HYPOXIA, PREGNANCY AND SYSTEMIC VASCULAR CONTROL

Local infusion of vasodilators and vasoconstrictors to determine the effects of pregnancy on forearm endothelial dependent and independent vascular responses and their alterations during pregnancies complicated by maternal hypoxia and/or preeclampsia..